Transcriptional and metabolic regulation of vaccine-elicited CD8+ T cell responses

PROJECT SUMMARY
Due to the overwhelming success of the new mRNA vaccines during the SARS-CoV2 pandemic, vaccines have
entered the public consciousness to a level not seen since the days of smallpox eradication and the polio
epidemic. It seems reasonable to assume that the established rules governing T cell responses to infections
might be useful in developing better subunit vaccine formulations. However, there is mounting evidence that the
immunological mechanisms relevant to adjuvant-elicited cellular immunity are vastly different than those
observed in response to infectious challenge. Over the last 20 years, we have published extensively on a growing
list of factors that highlight the mechanistic distinctions between vaccine-elicited (Tvacs) and infection-elicited
(Tinf) T cell responses in mice and non-human primates. Our most recent data has revealed additional features
mechanistically unique to Tvacs. Whereas Tinf split their functions between 2 different cell types and either divide
or become memory, Tvacs do both within the same cell. Our data support an entirely novel model of CD8+ T
cell activation whereby two transcription factors normally opposed to one another in function instead cooperate
to sustain Tvacs exponential clonal expansion as well as a memory cell fate. The goals of this project will be to
understand how these transcription factors cooperate instead of competing to support a vaccine-elicited T cell's
transcriptional and metabolic needs.

Public health relevance
PROJECT NARRATIVE One of the major challenges in vaccine development is access to adjuvants that promote long lived pathogen specific CD4+ and CD8+ T cell responses and provide protective cell mediated immunity. Our previous studies identified an adjuvant that induces protective long lived T cell populations in mice and primates but why this approach is so effective is unclear. Using next generation sequencing methods, we looked at what genes our vaccine-elicited cells were expressing. We found a unique gene expression program, guided by 2 factors that normally mediate opposing cellular functions to one another in a T cell responding to an infection. The overall goals of this project are to investigate what cellular function each factor is supporting, and how these normally competitive factors cooperate to keep the vaccine-elicited T cell alive and growing.